Colorado Nutrition Obesity Research Center

This is an application for a 5 year competitive renewal for the Colorado Nutrition Obesity Research Center (NORC). The MISSION of the Colorado NORC is to advance the science of nutrition and obesity by facilitating interdisciplinary, collaborative, translational research and by fostering the development of the next generation of scientists in the Rocky Mountain region. We are in our 30th year of operation, and we now support 125 NORC Members, 26 Associate trainees, and 47 Associate faculty scientists and educators. Colorado NORC Members have a healthy, nutrition and obesity-related annual funding portfolio. Building upon a multi-million dollar institutional investment in nutrition and obesity research over the past 30 years, we have secured an additional investment in institutional resources over the next 5 years to support the Colorado NORC Programs and Cores and to support the administration, building operation, programmatic development, and recruitment/retention efforts, with the Anschutz Health and Wellness Center (AHWC). This investment is important, because the AHWC is the administrative home of our center, its programs, much of one of the biomedical research cores, and a substantive portion of our Members who are performing clinical and translational research on nutrition and obesity. The CENTRAL THEME of the Colorado NORC is the prevention and treatment of obesity and its metabolic complications across the lifespan, through better nutrition, lifestyle modifications, and medical treatments. We specifically build and foster interdisciplinary research on nutrition and obesity in five areas that have emerged naturally in our Research Base: 1) Early Life Influences; 2) Biological Sex Differences; 3) Exercise and Energy Expenditure; 4) Metabolic Regulation and Dysfunction; and 5) Nutrition and Weight Management Interventions for Better Health. The Colorado NORC has strong leadership with Dr. Paul MacLean (Director), Dr. Daniel Bessesen (Associate Director), and Dr. Darleen Sandoval (Associate Director). During this next funding cycle, they will be taking substantive steps to help NORC members engage in T3/T4 research for translation. After 30 years of operation, the Colorado has never been as well-positioned to advance the science of nutrition and obesity on so many fronts and to foster the next generation of leaders in these fields.

Public health relevance
A. OVERALL COMPONENT Project Narrative The Colorado NORC will advance the science of nutrition and obesity by facilitating interdisciplinary, collaborative, translational research and by fostering the development of the next generation of scientists in the Rocky Mountain region. The Colorado NORC will accomplish this mission by supporting a research base of 125 funded scientists and their trainees with a pilot program, an enrichment program, and three biomedical research cores.